Elucidating neural circuits and pupil readouts of motivated effortful listening

Project Summary .
Attending to a speaker in a noisy environment, such as a cocktail party, can be an effortless and
pleasantly immersive experience for individuals with normal hearing and cognitive function. However, for
individuals with hearing loss, this ‘listening effort’ is their primary complaint, and can be a severe source of stress
and fatigue that impacts their quality of life and employment. Unlike an audiogram, which can be measured
objectively, listening effort is a high-level cognitive process, and challenging to measure. Pupillometry, measuring
the size of the pupil of the eye, has proven extremely useful as a physiological readout of listening effort.
However, we have very little understanding about the neural interactions underlie mental effort, and therefore do
not know what the pupil tells us, specifically, about these circuits. Experiments are needed that behaviorally
engage listening effort while probing the underlying neural circuits mechanisms, and determining which circuit
interactions are read out by pupil dilation. Our laboratory has recently developed a behavioral approach to study
the attentional component of listening effort (attentional effort), in mice. Mice report detection of temporal
coherence in ongoing noise by licking for sugar reward. We parametrically vary the difficulty on each trial, and
manipulate listening effort by changing reward volume in blocks of trials. We find that mice expend more
attentional effort during high-reward blocks, resulting in better detection of temporal coherence during blocks. In
parallel work, we have extensively characterized the physiological correlates in the auditory system of several
pupillometry metrics during a simpler auditory detection behavior. Furthermore, human and animal work
consistently show that frontal cortex structures that combine task performance and motivational information are
active during attentional effort. These results lead to the following central hypothesis: differences in cortical
coding between states of low and high reward, result from changes in modulation on fast and slow time scales,
together with auditory-frontal interactions that enhance coding of high-value sounds and provide feedback
signals that improve subsequent performance, and that these circuits are upregulated after hearing loss. We will
test this hypothesis by electrically recording from neurons in the auditory cortex and assaying their coding of
sounds, while two-photon imaging or optopgenetically manipulating inputs from neuromodulatory systems or
frontal cortex, and doing pupillometry during our listening effort task. Our results will reveal the contributions of
neuromodulatory and frontal cortex inputs to auditory cortex to shifts in listening effort allocated to temporal
coherence detection, and will directly relate multiple pupil metrics and statistical modeling approaches to these
circuit mechanisms.

Public health relevance
Project Narrative . Mental effort to comprehend speech in noisy environments is the primary complaint of patients with hearing loss. To pinpoint the circuit mechanisms underlying this listening effort, we will measure and perturb neuromodulatory and frontal cortical circuit interactions with auditory cortex, while mice engage in a challenging listening task that requires strategic shifts in effort allocation, to understand their role in attentional effort. We will evaluate pupil readouts of these circuit interactions, which will help to refine cochlear implant and hearing aid design to minimize listening effort, and help screen patient populations for vulnerability to listening stress and fatigue.